Statistical Methods for Analyzing Complex, Multi-dimensional Data from Cross-sectional and Longitudinal Mental Health Studies

Project Summary
To address the burden of mental illness, National institute of Mental Health encourages development of
computational approaches that provide novel ways to understand relationships among complex, large datasets
to further the understanding of the underlying pathophysiology of mental diseases. These datasets are multi-
dimensional, including clinical assessments, behavioral symptoms, biological measurements such as neu-
roimaging and psychophysiological data. The overall objective of this grant is to advance methodology for
analyzing such data to more effectively extract relevant information that are predictive of disease, to improve
the understanding of individual variability in clinical and neurobiological phenotypes, and to provide the capac-
ity to handle both cross-sectional and longitudinal data.
Our proposal will leverage two civilian trauma cohorts recruited through the Grady Trauma Project and
the Grady Emergency Department Study, and an external validation cohort from the Hill Center study with a
similar distribution of trauma exposure. We propose to develop statistically principled, computationally efﬁ-
cient statistical learning methods for addressing key challenges in analyzing these large datasets. Challenges
include multi-type outcomes, high dimensional data with sparse signals and high noise levels, spatial and tem-
poral dependence of neuroimaging data, and heterogeneous effects across patient population. The scientiﬁc
premise of this computational psychiatry research is that analytical methods integrating information
from brain, behavior, and symptoms will provide much-needed data driven platforms for improving
diagnosis and prediction of PTSD and other mental disorders.
In this application, we propose: (1) to develop partial generalized tensor regression methods and partial
tensor quantile regression methods that can simultaneously achieve accurate prediction of clinical outcomes
and efﬁcient feature extraction from high dimensional neuroimaging biomarkers; (2) to develop tensor response
quantile regression methods and global inference that can achieve comprehensive and robust understanding
of the heterogeneity in high-dimensional neuroimaging phenotypes in terms of environmental factors such as
trauma exposure; and (3) to develop and extend methods in Aims 1 and 2 for longitudinal multi-dimensional
data that will enable prediction of future post-trauma symptom severity trajectories in terms of neuroimaging
biomarkers and robustify the evaluation of the impact of psychophysiological factors on neuroimaging phe-
notypes. The proposed methods will be applied to the two Grady studies to address scientiﬁc hypotheses
relevant to PTSD research. We will use the Hill Center study as an independent validation cohort to evaluate
the reproducibility and generalizability of the ﬁndings. User-friendly software will be developed. The proposed
methodology is generally applicable to many other mental health studies with complex multi-dimensional data.

Public health relevance
Narrative We propose to develop statistical methods for analyzing large-scale and multi-dimensional data in mental health studies to more effectively extract relevant information that are predictive of disease and to help understand individual variability in clinical and neurobiological phenotypes. The applications of the proposed methods will generate new knowledge to further the understanding of the mechanism and progression of the PTSD that will lead to improved disease management strategies.